NATIONAL STANDARD FOR NORMAL FETAL GROWTH - DATA COORD CTR

The primary goals of the study are to acquire reliable and valid data to: (1) establish a U.S. national standard for normal fetal growth (velocity) and size for gestational age; (2) create an indiviuallized standard for optimal fetal growth and size; (3) improve accuracy of fetal weight estimation based on the ultrasound measures; and (4) construct an individualized standard for fundal height.